Microbial and host biomarker development for detection and prognosis of early stage non-small cell lung cancer

Project summary (OVERALL)
Lung cancer remains the leading cause of all cancer mortality. Improved imaging techniques enable the detection
of lung cancer at earlier stages, yet a large number of patients with non-malignant lung nodules are frequently
subjected to invasive diagnostic approaches. Even though surgical removal of early stage non-small cell lung
cancer (NSCLC) is the most effective therapy, post-surgical recurrence of NSCLC remains a significant problem
as survival. Currently there are no clinically useful biomarkers that can accurately diagnose the indeterminate
nodule or identify those patients destined to have recurrence of cancer after successful surgical removal.
Recently, the use of culture-independent techniques to characterize the microbiome by us and others has led to
identification of microbial signatures associated with lung cancer diagnosis and prognosis among a cohort with
a wide range of disease stages. Preliminary metagenomic data obtained in collaboration with Micronoma using
blood samples of our NYU cohort have identified microbial signatures in systemic circulation associated with
early-stage NSCLC diagnosis. Further, using a NanoString platform we have identified circulating RNA
signatures predictive of early-stage NSCLC diagnosis. In addition, our preliminary data shows that lower airway
signatures can be used to predict prognosis post-surgical removal of early stage cancer. These data suggest
that microbial and host genomic signatures could be leveraged to develop useful biomarkers in early-stage
NSCLC. The addition of metabolite measurements could further contribute to this predictive power since those
are end products of microbial and host functions. Under this BCC application we will first identify top
microbial/host biomarkers that predict early-stage NSCLC diagnosis and prognosis using blood and lower airway
samples from a cohort of patients with lung nodules and a presumed surgical clinical Stage I (<3cm) but with a
final histological diagnosis of early-stage NSCLC (TNM  IIIA) or non-NSCLC nodules. We will implement cutting
edge bioinformatic approaches to identify the most promising targets from these unbiased omic approach
(metagenome, metabolome and transcriptome) which will guide the development of targeted approaches that to
be validated under the Biomarker Reference Laboratory. These targeted approaches will include the
development of targeted microbial DNA next generation sequencing, targeted metabolite measurement and
custom-made NanoString panels as CLIA level assays, internally and externally validated, that will identify
patients at highest risk for NSCLC diagnosis and recurrence after complete surgical resection.

Public health relevance
Narrative. The diagnosis and prognosis of early stage lung cancer, the leading cause of cancer deaths in the U.S., is challenging and there are no useful biomarkers leading to unnecessary invasive tests and poor outcome among those that have recurrence of disease. In this project, we will uncover microbial and host signatures to develop tests that can predict diagnosis and prognosis of early stage lung cancer.